Multi-Tissue MAFLD Chip for Mechanism-Based Drug Testing

Project Summary
Metabolic-associated fatty liver disease (MAFLD) is a pathophysiological spectrum disorder affecting 20-
40% of adults in developed countries. MAFLD etiology is complex, influenced by multiple organs, environmental,
and genetic factors in what is referred to as the “multiple parallel-hit model” of disease. Dysregulated metabolic
signals axes (e.g., gut-liver and liver-adipose) and pathways (e.g., peripheral insulin resistance (IR)) are
elements of the multi-hit model that drive the development and progression of MAFLD hallmarks including
steatosis, steatohepatitis, and fibrosis.
As of today, there are no FDA-approved therapies specific for MAFLD/NAFLD. Dozens of companies
have invested in MAFLD drug development programs competing to be first-to-market with a treatment. However,
recent high-profile failures of Phase III trials highlight the challenge to win approval for monotherapies to treat
MAFLD. Given the pathological complexity of MAFLD and the limited efficacy of mono-therapeutic approaches,
the pharmaceutical industry has begun to develop strategies for combinatorial therapies that will engage several
targets/pathways simultaneously to improve the clinical outcomes.
One of the major challenges in the identification of drug combinations to treat MAFLD is the limitation of
the current preclinical drug discovery platforms for complex diseases. While animal models are commonly used
in late drug discovery phase, they are not suitable for “exploratory” combinatorial studies due to cost and ethical
concerns. On the other hand, current in vitro models of MAFLD are designed to investigate liver only
pathophysiologies.
To address this limitation, we propose developing an interconnected liver-adipose MAFLD tissue chip to
test drugs and drug combinations targeting mechanistic drivers of disease in the context of the gut-liver-adipose
(GLA) signaling axis. This drug testing platform combines a liver-adipose microphysiological system (MPS) that
recreates key aspects of the multi-hit hypothesis of MAFLD in the context of GLA signaling axis, and systems
biology (SB)-based workflows to evaluate mono- and combinatorial therapies’ efficacy and mechanism of action.
The drugs and drug combination will be tested on tissue chips for their efficacy and the results, both phenotypic
and multi-omics, will be used with our systems biology-based computational workflow - genome-scale metabolic
network models (GEMs) to gain mechanistic insights. GEMs will be constructed and validated using
transcriptomics and metabolomics data, respectively.
We believe that our platform will enable mechanism-based drug efficacy evaluation for mono- and
combination therapies at the preclinical discovery stage prior to animal studies. This will reduce the cost and
timeline to identify combination therapies for MAFLD and improve long-term clinical outcomes.

Public health relevance
Project Narrative Metabolic-associated fatty liver disease (MAFLD) is a complex disease exhibiting variability in morbidity and mortality, which is influenced by multiple tissues including the gut, liver, and adipose. Javelin Biotech’s project establishes a preclinical drug testing platform combining a human cell-based tissue chip and systems biology- based workflows to study drug efficacy for MAFLD progression. Our novel platform will enable mechanism of action-based drug testing for mono- and combinatorial treatments at the lead optimization stage prior to animal studies, thereby reducing the cost and timeline to identify combinatorial therapies targeting multiple pathophysiologies in MAFLD.